Structural Identification and Functional Consequences of Different Amyloid Strains in Alzheimer's Disease

Alzheimer's disease is associated with the deposition of amyloid in the brain during aging. Since the
correlation between amyloid formation and AD was originally made, it has been recognized that there are
many subtypes and forms that the disease can take. For example, accumulation of the amyloid β-protein (Aβ)
in the brain parenchyma is the hallmark of Alzheimer's disease (AD). Nevertheless, there is a poor
understanding as to why amyloid forms, and it is not known whether there are unique structural motifs that
promote the distinct pathological consequences leading to dementia. The focus of this proposal is to fill this
critical void in knowledge. Accordingly, the overall hypothesis of this proposal is that the Aβ peptides forming
amyloid with distinct subtypes have distinct structures that determine their location and pathology. To address
this hypothesis we propose two specific aims.
First, we plan to isolate amyloid from different subtypes of post mortem brain tissue of late-onset AD and early-
onset familial AD. We plan to compare five different amyloid plaque subtypes: typical AD, atypical AD, cotton
wool, early-onset AD (EOAD) and very early-onset AD (VEOAD). The last two subtypes are associated with
familial AD mutations. Clinical information is available concerning age and gender, age of onset and duration of
disease, course and symptoms of the disease, medication and ApoE genotype. In the EOAD and VEOAD
cases genetic testing was performed for APP, PSEN 1, PSEN2 and tau. For most cases, biomarkers in CSF
and neuroimaging results are available. The isolated amyloid will serve as seeds to nucleate fibril growth for in
vitro studies. The structure and polymorphism of the fibrils will be assessed by complementary structural
approaches including solid-state NMR spectroscopy, Fourier transform infrared spectroscopy, transmission
electron microscopy, and atomic force microscopy.
Using the amyloid isolated from the five different subtypes of AD, we will assess the biofunctional
consequences of the different strains using three approaches. First, we will assess the differences in the
inflammatory response and cell toxicity due to different fibril forms using microglial cell cultures. Second, we
will determine the influence of amyloid strains on promoting neuroinflammation. Third, we will determine the
influence of amyloid strains on assembly and propagation in rat brain.
The overall objective is to correlate pathologies (biofunctional consequences) of different amyloid subtypes
between cell culture, rat brain and human brain, and to relate these pathologies with specific structural
characteristics of the Aβ fibrils that are associated with the isolated amyloid from each subtype.

Public health relevance
Amyloid-β (Aβ) protein assembly and deposition in the brain parenchyma are key pathological features of Alzheimer's disease (AD). Recent studies have shown the Aβ protein can assemble into different structures and that these structures maybe associated with different subtypes of AD. We propose to determine the structural composition of Aβ fibrils in 5 different subtypes of AD and the associated functional consequences of these structures.